Role of skeletal muscle IPMK in nutrient metabolism and exercise

SUMMARY
Inositol phosphates are critical signaling messengers involved in a wide range of biological pathways in which
inositol polyphosphate multikinase (IPMK) functions as a rate limiting enzyme for inositol polyphosphate
metabolism. Many laboratories including ours have studied the biology of IPMK mostly in cellular models. IPMK
has been implicated in metabolism but its tissue-specific function at the systemic level is poorly understood.
IPMK is highly expressed in skeletal muscle, and the levels are increased with exercise and decreased in
diabetes. Skeletal muscle is a major contributor to energy homeostasis, therefore, we have developed mouse
and cellular models to elucidate metabolic mechanisms of IPMK. We have found that mice in which IPMK is
specifically deleted in skeletal muscle (MKO) displayed disrupted nutrient utilization, impaired glucose tolerance
and reduced exercise tolerance compared to the control mice. Moreover, global metabolic and biochemical
analyses revealed disrupted mitochondrial functions, reduced beta-oxidation and impaired insulin response in
ipmk deficient muscle cells. In addition, we found that IPMK regulates the levels of acetylation via histone protein
deacetylases, which plays a key role in metabolism. Based on our previous research and preliminary data, we
hypothesize that skeletal muscle IPMK plays critical roles in nutrient utilization and energy homeostasis. We
propose four specific aims. In Aim 1, we will investigate the in vivo actions of muscle IPMK on fuel utilization at
rest and during exercise. In Aim 2, we will examine how muscle IPMK regulates whole-body metabolism and its
response to exercise. In Aim 3, we will investigate how IPMK regulates nutrient utilization in myocytes using
biochemical, cellular and molecular approaches combined with chemical genetics to modulate IPMK activity. In
Aim 4, we will investigate the transcriptional mechanisms by which IPMK modulates energy utilization using
biochemical, transcriptomic and bioinformatic approaches. Together, this project is expected to advance the field
by filling a critical gap in understanding of the biology of IPMK in energy homeostasis. Our proposed studies will
illuminate the key functions of skeletal muscle in metabolism and could potentially lead to the development of
new therapies for diabetes, obesity and related diseases.

Public health relevance
PUBLIC RELEVANCE More than a third of adults in the United States are obese, as a result of overeating and sedentary lifestyle and obesity increases the risk for diabetes, heart disease, stroke, cancer, and other health problems. The goal of this project is to study the role of a novel energy-sensing enzyme, Inositol Polyphosphate Multikinase (IPMK), in muscle function and whole body metabolism under normal and overnutrition conditions. We anticipate that our research in mouse and cellular models will reveal how disruption of IPMK pathways in muscle potentially predisposes to obesity, diabetes and abnormal lipid metabolism.